UAB-HudsonAlpha Genomic Medicine Training Program

Project Summary
The UAB-HudsonAlpha Genomic Medicine Training Program was established four years ago to train
leaders in the integration of genetics and genomics into medical practice. We have recruited fellows with
an MD, PhD, or PharmD degree who participate in customized educational training and pursue mentored
research at UAB or HudsonAlpha. The educational plan is based on a set of competencies that equip the
trainee with the knowledge and skill set to be an independent genomic medicine researcher. Each trainee
also completes a genomic medicine practicum that provides exposure to clinics and clinical laboratories,
an educational outreach project, an opportunity to explore entrepreneurship career opportunities, and
training in the responsible conduct of research and rigor and reproducibility in research. The trainees
carry out mentored research under the auspices of one of 60 program faculty, as part of an individualized
development plan. Conferences at UAB and HudsonAlpha include research seminars, genome
sequencing case review conferences, a molecular tumor board, and a monthly genomic medicine
meeting, which provide a foundation and common platform for all trainees. All trainees attend the annual
NHGRI training conference and present either posters or platform presentations and present their work
at a Work in Progress seminar at UAB. Trainee progress is monitored in biannual written reports and
meetings with each trainee and mentor together with the program co-directors. Several innovations
have been instituted since the inception of the program four years ago. These include the monthly
genomic medicine conference and the entrepreneurship practicum; the latter leverages the strong
relationship of HudsonAlpha with biotechnology companies hosted on the HudsonAlpha campus. In
order to increase our ability to recruit MDs, we have forged relationships with the UAB Department of
Surgery and Department of Medicine, both of which have programs that enable residents to pursue two
or more years of research during the course of their training. We have also added an introductory lecture
series on the basics of genomic medicine to ensure that all trainees are equipped with basic skills in
genomic medicine, including, for example, data management and sharing. The required education in
Rigor and Reproducibility in Research is also a new addition. We have strengthened our outreach efforts
to enhance the recruitment of minorities to the program. This includes leveraging relationships we have
forged with Historically Black Colleges and Universities in Alabama through our R25 DAP program
“Summer Undergraduate Experience in Genomic Medicine (SURE-GM)” and with the Muscogee (Creek)
Nation. Finally, we have adapted a program evaluation approach initially developed for SURE-GM to
provide formal evaluation of our T32 Genomic Medicine Training Program.

Public health relevance
Project Narrative The UAB-HudsonAlpha Genomic Medicine Training Program seeks to train the next generation of MDs, PhDs, and PharmDs to be leaders in the integration of genomics into medical practice. The core of the program is mentored research in genomic medicine at UAB and at HudsonAlpha. A rich set of educational offerings, as well as experiences in clinics and clinical laboratories, public outreach and education, and entrepreneurship are tailored to the individual needs of each trainee.